NIH StrokeNet Regional Coordinating Center - University of Pittsburgh (STN-UP)

Abstract
The NINDS Stroke Net Regional Coordinating Center (RCC) at the University of Pittsburgh (STN-UP) will continue to build on its successful infrastructure and experience from previous funding cycles to support regulatory efficiency, academic expertise, and high-quality performance in Stroke Net trials focused on stroke prevention, treatment, and recovery. Our large STN-UP research network includes University of Pittsburgh Medical Center (UPMC) and St. Luke’s University Health hospitals, covering large urban, suburban, and rural areas of Pennsylvania, to support high trial recruitment of stroke participants with diverse backgrounds. The STN-UP research fellowship has trained 8 clinician investigators that have gone on to successful academic careers. We have also supported the larger national network through our participation in the Executive Committee, Working Groups for Stroke Prevention, Rehabilitation and Recovery, Educational Core, Remote Telemedicine Advisory Group and Endovascular Trial Platform Executive Committee. Grounded in these strengths, the specific aims of the STN-UP RCC in this proposal are to: 1. Continue to improve our collaborative and administrative structure to rapidly implement Stroke Net trials and enroll patients across a wide range of adult and pediatric populations. 2. Foster participation of physicians, patients, and patient support groups with equitable representation of women and minorities to meet or exceed accrual requirements. 3. Promote career development of young clinician-investigators in stoke neurology. STN-UP will be led by the Program Director, Marcelo Rocha, MD, PhD and co-Program Director Raul Nogueira, MD. Strengths of the STN-UP to continue its contributions as a NIH Stroke Net RCC are: 1) Consistent track record of high enrollment in NINDS and industry clinical trials. 2) Over 2000 yearly stroke admissions at UPMC core hospitals (UPMC Presbyterian-Shadyside and UPMC Mercy). 3) Large tele stroke network including 39 hospitals in western and central Pennsylvania, and Maryland, with prior experience recruiting patients into stroke trials after telemedicine evaluation. 4) Extensive community referral network with tele-medicine support throughout the tri-state area and CTSI resources to foster bi-directional research partnerships in underserved areas. 5) Participation in NIH Stroke Net, NeuroNEXT and SIREN networks, and institutional support for tier-1 federated IRB and master clinical trial agreements. To continue the commitment of training the “next generation” of qualified stroke researchers, the STN-UP will: 1) Maintain our dedicated stroke research fellowship including formal training in clinical research methods and mentored research projects. 2) Recruit trainees to the Advisory Committee on a rotating basis. 3) Provide clinical trials education and experience for residents, fellows, junior faculty and clinical research coordinators.

Public health relevance
Project Narrative The Stroke Net Regional Coordinating Center-University of Pittsburgh (STN-UP) will continue to leverage the regional dominance of UPMC in healthcare, the CTSI, existing clinical research collaborations at the University of Pittsburgh and other institutional resources for its successful clinical trials infrastructure. The STN-UP will continue practices that have led to successful trial recruitment and regional research network administration, while adopting new measures to further increase efficiency and capacity for entering patients into trials with equitable representation of women and minorities, and contribute to the educational, collaborative, and administrative functions of the National Clinical Coordinating Center (NCC), the National Data Management Center (NDMC) and the overall network. The combined efforts of NIH Stroke Net and STN-UP will ensure that diverse patients have access to impactful stroke trials and maintain specialized training for clinician researchers.